Quantitative analysis of LC-MS data for peptide and glycan biomarker discovery

DESCRIPTION (provided by applicant): PROJECT SUMMARY Label-free quantification of analytes using liquid chromatography-mass spectrometry (LC-MS) is gaining recognition as a very good strategy for biomarker discovery. However, such quantification is not addressed adequately in the instrument-specific software packages. In particular, alignment of LC-MS data presents a significant challenge in label-free quantification and comparison of biomolecules. This challenge coupled with biological variability and disease heterogeneity in human populations has restricted recent advances in LC- MS-based biomarker discovery studies. This project brings together experts in bioinformatics, biostatistics, biochemistry, clinical cancer research, chromatography, and mass spectrometry to develop novel analytical tools for LC-MS-based label-free quantification and comparison of glycans and peptides in serum and plasma. Specifically, a novel probabilistic-based mixture regression model and a new clustering-based method will be investigated for alignment of LC-MS data and for identification of patient subgroups. LC-MS data from spike-in studies will be utilized to develop and optimize the proposed alignment methods and to compare their performance with other existing solutions. The optimized algorithms and statistical methods will be applied to identify peptide and glycan candidate biomarkers for early detection of HCC. This will be accomplished by using two LC-MS technologies to evaluate the expression of peptides and glycans in serum and plasma samples collected from HCC patients and cirrhotic controls. The candidate biomarkers will be validated using isotope dilution mass spectrometric assays. Our proposal to perform both peptide and glycan profiling studies based on serum and plasma samples from the same participants is a unique opportunity to explore an integromic approach for marker discovery. Furthermore, this project will capitalize on markers identified in this study and other previous studies to investigate key metabolic and signaling pathways that may be related to the progression of HCC. This will enhance our understanding of the disease progression and the functional involvement of the markers in metabolic and signaling pathways, which could be used to design and test improved treatment strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE This project will lead to the development of novel open source analytical tools for label-free quantification of peptides and glycans in serum and plasma using liquid chromatography-mass spectrometry (LC-MS) technologies. The availability of such tools will assist the research community in advancing the promising LC- MS-based biomarker discovery research. The proposed tools will be utilized to find and validate early- diagnosis biomarkers of hepatocellular carcinoma (HCC). Defining clinically applicable biomarkers that detect early-stage HCC in a high-risk population of cirrhotic patients has potentially far-reaching consequences for disease management and patient health. This project is important because most HCC patients are diagnosed at a late stage, where the treatment options are limited. There is a pressing need to identify biomarkers that could be used for early detection of HCC. In addition to screening high-risk populations for early signs of disease, the resulting biomarkers could be used to design and test improved treatment strategies. PROJECT NARRATIVE This project will lead to the development of novel open source analytical tools for label-free quantification of peptides and glycans in serum and plasma using liquid chromatography-mass spectrometry (LC-MS) technologies. The availability of such tools will assist the research community in advancing the promising LC- MS-based biomarker discovery research. The proposed tools will be utilized to find and validate early- diagnosis biomarkers of hepatocellular carcinoma (HCC). Defining clinically applicable biomarkers that detect early-stage HCC in a high-risk population of cirrhotic patients has potentially far-reaching consequences for disease management and patient health. This project is important because most HCC patients are diagnosed at a late stage, where the treatment options are limited. There is a pressing need to identify biomarkers that could be used for early detection of HCC. In addition to screening high-risk populations for early signs of disease, the resulting biomarkers could be used to design and test improved treatment strategies. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Liquid chromatography-mass spectrometry (LC-MS) is a powerful and sensitive technology that has the capability to detect changes in peptide and glycan expression levels. While some of these changes may stem from biological differences related to a disease under study, others may reflect the heterogeneity of patients, the inherent biological complexity and diversity among different samples, and differences in sample collection, sample processing, and instrument settings. These problems have significantly restricted LC-MS-based studies for eliciting differences in peptide/glycan expression patterns. This project brings together experts in bioinformatics, biostatistics, biochemistry, clinical cancer research, chromatography, and mass spectrometry to develop computational and analytical methods to evaluate peptides and glycans in the progression of cirrhosis to hepatocellular carcinoma (HCC). This will be accomplished by label-free quantification of glycans and peptides in serum and plasma by two complementary LC-MS technologies: (1) LC coupled to a mass spectrometer through electrospray ionization (LC-ESI-MS) and (2) offline coupling of LC to matrix-assisted laser desorption-ionization time-of-flight (LC-MALDI-TOF). In addition, this project will capitalize on candidate biomarkers discovered in this and other studies to identify key metabolic and signaling pathways that would enable us to better understand the progression of HCC. The specific aims of the project are: Specific Aim 1. Develop a probabilistic-based mixture regression model for alignment of LC-ESI-MS data. We propose to develop a novel computational method that automatically detects patient subgroups based on LC-ESI-MS profiles. The proposed method accomplishes this while aligning the LC-ESI-MS data to ensure bias-free comparison of the same species in multiple LC-ESI-MS runs. Specifically, we will develop a probabilistic-based mixture regression model (PMRM) that utilizes the expectation maximization algorithm to estimate the joint parameters of spline-based mixture regression models and prior transformation density models. A particular advantage of this approach is its ability to model non-Gaussian multi-modal density functions using simpler component density functions that can be defined on non-vector data. Difference detection will be carried out by comparing the subgroups identified by PMRM. This approach is expected to identify patient subgroups and to improve the discriminating power of the markers by reducing the influence of the biological variability and disease heterogeneity. Furthermore, it will provide the ability to capture markers that are differentially abundant in only a subset of patients and that may be missed by metrics that work under the comparison of two prelabeled phenotypic groups. We will optimize the parameters of PMRM through spike- in LC-ESI-MS data. Specific Aim 2. Develop a clustering-based method for alignment of LC-MALDI-TOF data. We propose to investigate a new clustering-based alignment algorithm for analysis of LC-MALDI-TOF data. An important step in any cluster analysis is to select an appropriate metric to determine the similarity of two objects. We will define a new metric that takes into account not only the mass-to-charge ratio (m/z) and retention time (RT) values, but also the measurements of the peak intensities. We will use this partition-based clustering method to search for clusters of peaks. A nonlinear regression method will be utilized to model the relationship between the three dimensions (m/z, RT, and peak intensity) and RT deviation. The model will be utilized to predict and correct the RT shifts for all peaks. We will optimize the algorithm through spike-in LC-MALDI-TOF data. Specific Aim 3. Identify candidate peptide and glycan biomarkers for early detection of HCC. We propose to collect serum and plasma samples, generate both LC-ESI-MS and LC-MALDI-TOF data, and utilize the alignment methods developed in Specific Aims 1 and 2 to evaluate the expression of peptides and glycans in the progression of cirrhosis to HCC. The samples will be collected from newly diagnosed HCC cases and cirrhosis controls recruited at Georgetown University Hospital in collaboration with Drs. Radoslav Goldman, Aiwe Ruth He, and Kirti Shetty. Candidate peptide biomarkers will be sequenced and their ability to distinguish HCC from cirrhosis will be examined using isotope dilution through 13C-labeled synthetic peptide standards quantified by multiple reaction monitoring on triple quadrupole mass spectrometers. Also, we will confirm differences in glycan abundance using the comparative glycomic mapping (C-GlycoMAP) isotopic labeling. Specific Aim 4. Identify key pathways enriched by multiple candidate biomarkers of HCC. We propose to conduct network and pathway analyses by using candidate biomarkers discovered in this study and those reported in previous omics studies. We will investigate pathways affected by HCC biomarkers to determine the functional roles of the biomarkers in metabolic and signaling pathways at various levels. This aim will test the hypothesis that better understanding of the progression of HCC can be achieved through a pathway-centric approach by integrating experimental findings from multiple studies instead of studying individual biomarkers.